Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Administrative Core will provide the structure for effective and efficient operation and maintenance of the Washington University Advancing Cancer Control Engaged Research through Transformative Solutions (WashU-ACCERT), while engaging with community and leveraging innovative opportunities to promote cancer control community engagement. The Administrative Core will support an environment of research excellence, scientific innovation, community engagement, and multidisciplinary scholarship within WashU-ACCERT and among other centers of the NCI ACCERT consortium. The Administrative Core will manage and coordinate all WashU-ACCERT operational and scientific activities, within a cohesive organizing framework, including fiscal management, evaluation, communication, and dissemination to advance cancer control community engagement by stimulating community- engaged, multi-level research that addresses the impact of healthcare access, affordability, availability, attainability, accommodation, and acceptability factors on adverse cancer control outcomes. The Administrative Core will support the overall mission of the WashU-ACCERT through the following aims: (1) Envision and sustain the operational structure, scientific leadership, and community engagement for WashU- ACCERT to maximize efficiency, effectiveness, and accountability; (2) Service in leadership that results in dissemination, collaboration, and networking within WashU-ACCERT and across the consortium of centers, including the coordinating center; (3) Cultivate and champion research and partnership capabilities among well-rounded team of scholars and community partners; (4) Evaluate all WashU-ACCERT activities and provide feedback to refine ongoing activities; (5) Establish a timeline and milestones to monitor progress and coordinate efforts. The leadership, operational structures, and processes of the Administrative Core will position WashU-ACCERT to engage with the community across Missouri and Illinois to conduct high-quality, high-impact science and to improve access to care and improve cancer health for all. WashU-ACCERT investigators have substantial expertise and a proven track record in conducting collaborative, community-engaged science in cancer control, including multi-level interventions addressing the impact of healthcare access, affordability, availability, attainability, accommodation, and acceptability factors, as well as in disseminating findings to researchers and the community. We will advance the field of cancer control research, drawing from our Center’s distinctive features that include a record of cancer engaged research, rigorous community engagement, and the application of strategies to conduct rapid-cycle studies. The Administrative Core is a critical element of the overall scientific program and infrastructure for the Center and provides a strong foundation for scholarly excellence, research synergy, and clinical and community impact.